Case Comprehensive Cancer Center Support Grant

Title of the Project: BER Inhibitor TRC102 added to Standard Pemetrexed-Platinum-
Radiation in Stage III Non-Squamous Non-Small Cell Lung Cancer
Project Summary/Abstract
This application is being submitted to request for an administrative supplement through
the P30 CA043703-24 for the approved LOI #10512 (BER Inhibitor TRC102 added to
Standard Pemetrexed-Platinum-Radiation in Stage III Non-Squamous Non-Small Cell
Lung Cancer).
The Case Comprehensive Cancer Center (Case CCC) has a long track record in
conducting early phase clinical trials with a variety of sponsors, including pharmaceutical,
physician-investigator and CTEP sponsored studies. Seidman Cancer Center, a member
of the Case CCC, enrolls over 120 patients per year in early phase trials. It has a
significant infrastructure in place that allows for rapid study activation, patient accrual and
enrollment of patients with uncommon genomic abnormalities, minority accrual, quality
nursing, and data management. The structure of the phase I program engages
physicians from disease sub-specialties. The quality assurance program and regular
weekly staff meetings provide internal oversight. Recently the LOI# 10512 was
approved by CTEP to open a phase IIR clinical trial through ETCTN. Through the
requested administrative supplement (EDDOP), we hope to be able to open and complete
the clinical trial with CTEP.

Public health relevance
Project Narrative This will be a phase II randomized clinical trial evaluating the combination of TRC102, a novel base excision repair inhibitor, with pemetrexed and cisplatin to improve radio- sensitization in the treatment of stage III non-squamous non-small cell lung cancer [ 1,2,3,4,5,6,7 ]. The primary goal is to improve the 12-month PFS from 56% with standard therapy to 75% with the experimental treatment. We will accrue a minimum of seven patients annually to CTEP ETCTN studies.